A Mobile App Based Cognitive Dissonance Intervention for Smoking Cessation

Abstract
Despite overall declines in the rate of tobacco use in the United States over the past 30 years, nearly 38
million Americans still smoke, posing extremely high risk for long-term health problems and death. Recent
reviews note that there has been significant progress in the application of both clinical and public health
interventions to help smokers quit; however, they have also concluded that the overall success rate of smokers
quitting has not significantly improved. Individual, group and public health interventions – both with and without
adjunctive aids such as nicotine replacement therapy – have generally used some combination of cognitive-
behavioral interventions, but there remains a need for novel, theory-driven approaches to enhance quit rates.
Innovative interventions such as those offered via computer or mobile app can increase reach and
engagement. We propose to adapt and test the feasibility of a previously piloted cognitive dissonance
intervention (CDI) for smoking cessation delivered via a mobile app. Cognitive dissonance interventions have
been shown to be successful in treating health-related problems, as well as substance use, and preliminary
findings support its use in smoking cessation. The program, entitled CoQuit, is based on cognitive dissonance
and smoking cessation components tested in our Phase I prototype mobile app. This prototype app
demonstrated efficacy and the results of our evaluation study met criteria for moving to Phase II. We will
expand and revise the six module CoQuit program, which includes 12 video components (6 instructional
components and 6 cognitive dissonance activities) to improve ease of use, increase interactivity with other
smokers who are quitting, and improve social support elements in partnership with Emberex, who has
extensive experience in the development and commercialization of mobile apps. This development will assess
navigation and usability with adult daily smokers and conduct pilot testing to guide development of the CoQuit
app for evaluation. Our research and development team has extensive experience developing and testing
mobile apps and developing and testing cognitive dissonance and smoking cessation interventions. The
evaluation study will include 500 adults recruited through social media and randomly assigned to either the
Cognitive Dissonance mobile app or a comparable app without cognitive dissonance tasks; participants will be
assessed at baseline, 1- and 3-month follow-up. Significant changes in quit attempts, number of days without
smoking (smokefree days), point prevalence cessation, and changes in smoking attitudes will be used to
determine the efficacy of the CoQuit app. Usability data, system log data on program use, and participant
satisfaction data will also be analyzed.

Public health relevance
Project Narrative New, innovative, theory-driven approaches are needed to both improve the long-term quit rates, as well as to increase the reach of effective interventions. The proposed study aims to adapt and test the efficacy of a cognitive dissonance-based mobile app for smoking cessation (CoQuit). Following development, the CoQuit mobile app will be evaluated in a randomized evaluation trial with 500 adult smokers recruited through social media and evaluated for cessation outcomes and consumer satisfaction measures at 1 and 3 months after enrollment.